From Inflammation to Innovation: Harnessing Neutrophil Pathways to Combat Arrhythmogenic Cardiomyopathy

PROJECT SUMMARY
Arrhythmogenic cardiomyopathy (ACM) is an inherited heart disease and a leading cause of
sudden cardiac death. ACM is plagued by arrhythmias, cardiac dysfunction, and myocardial
inflammation; phenotypes recently shown to be driven, in part, by chronic immune signaling. Our lab
utilizes a mouse model of ACM (Dsg2mut/mut), that recapitulates key phenotypes observed in patients
with ACM. Importantly, cardiac dysfunction and arrhythmias precedes overt myocardial injury. Recently,
our lab demonstrated ACM cardiomyocytes release numerous cytokines, chemokines and DAMPs
(Chelko et al., JCI [2024] & STM [2021]), which act to recruit pro-inflammatory CCR2+ macrophages;
resulting in extensive myocardial cell death, inflammation, and fibrosis. This remodeling leads to cardiac
dysfunction, arrhythmias, and increased mortality. Almost certainly, immune signaling occurs prior to
disease onset and overt cardiac remodeling in ACM. Neutrophils are among the first cells to participate
in the immune response, such as the formation of neutrophil extracellular traps (NETs) and neutrophil
degranulation. In this proposal, we aim to investigate the role of two neutrophil-specific inflammatory
proteins: peptidyl arginine deiminase-4 (PAD4) and myeloperoxidase (MPO). Specifically, PAD4-
dependent NET formation and neutrophil-mediated MPO release prior to disease onset and throughout
disease progression in Dsg2mut/mut mice. Our prior published works and preliminary data presented here
demonstrate MPO and PAD4 are both upregulated in adolescent Dsg2mut/mut mice before phenotypes
are present. We hypothesize both PAD4 and MPO contribute to a cardiac inflammatory
environment, triggering immune cell chemotaxis, myocyte cell death, fibrotic remodeling, and
cardiac dysfunction. To directly test this hypothesis, (Aim 1) we will test the efficacy of the MPO
inhibitor, PF1355, in Dsg2mut/mut mice; and (Aim 2) genetically ablate Pad4 in Dsg2mut/mut mice. Both
approaches will elucidate whether neutrophil-mediated immune signaling drives ACM pathogenesis.
Outcomes from our work will determine if targeting neutrophil-mediated pathways could mitigate
disease progression, providing a new therapeutic strategy in combating immune-mediated myocardial
injury in affected individuals. This project will be completed at Florida State University College of
Medicine (FSUCOM) under the guidance of Drs. Stephen Chelko (Mentor) and Yi Ren (Co-mentor).
The training plan has been formulated to facilitate the development of both technical and conceptual
proficiencies to successfully execute the proposed aims. Additionally, the training plan incorporates
essential elements to transition the applicant into an independent scientific investigator. The Chelko
and Ren Laboratories, the Department of Biomedical Sciences at FSUCOM, and the FSU campus –
writ large – provides a rich scientific environment and outstanding graduate training for the applicant.

Public health relevance
PROJECT NARRATIVE Arrhythmogenic cardiomyopathy (ACM) is a familial heart disease, a leading cause of sudden cardiac death, and characterized by extensive myocardial inflammation – a defining pathological hallmark whose underlying pathogenesis and role in disease progression remains poorly understood. This proposal aims to identify how early immune responses, specifically neutrophil-induced pathways, contribute to both disease onset and the persistent immune-mediated disease progression in ACM. By targeting neutrophil-related proteins, we aim to elucidate the inflammatory mediators contributing to disease pathogenesis and new therapeutic strategies to reduce myocardial inflammation, prevent cardiac damage, and improve survival outcomes for patients living with ACM.